2023 Synthetic Biology Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
The 2023 Gordon Research Conference (GRC) on Synthetic Biology will provide a forum for junior and senior
scientists from related disciplines to share unpublished, innovative research about synthetic biology, including
its applications to solving problems in human health and disease and emerging societal impact. This biennial
meeting (with the exception of 2021) was established in 2013 by the GRC, an organization known
internationally for high-quality and cutting-edge meeting content. The specific objectives are to foster
interactions across the field, strengthen and expand the community of synthetic biology researchers, and
mentor students in a supportive setting. Invited speakers include prominent researchers and promising young
scientists from diverse backgrounds who apply new approaches to synthetic biology. In addition to the 20
invited speakers and 13 tentative speakers, all participants can present their research at highly interactive
poster sessions. A distinct feature of this meeting is its association with a student-organized Gordon Research
Seminar (GRS). The GRS invites ~50 graduate and postdoctoral trainees to present and discuss their research
ahead of the GRC. Senior investigators are invited to the GRS to provide advice and feedback to, thereby
nurturing the careers of future synthetic biology researchers. The 2019 GRC/GRS meetings received positive
reviews for presenting a variety of research topics and for promoting an informal, highly interactive format.
The 2023 Synthetic Biology GRC on Synthetic Biology will be held July 16-21, 2023 at the Grand Summit Hotel
at Sunday River in Newry, Maine, an ideal setting for encouraging invigorating discussions in a collegial
atmosphere. The GRS will be held July 15-16, 2023. A guiding principle is our commitment to explore novel
themes and to gather a completely new group of speakers for each biennial meeting. The specific program
described aims to represent the current state of the synthetic biology field, while also moving into applications
that can impact human health, our environment, and our society. Thus, the 2023 meeting will emphasize
research areas that apply synthetic biology to explore solutions to pressing human problems. As in years past,
we welcome industry, government, and military scientists as well as academic researchers, as this field has a
wealth of sub-specialties and applications. We are also committed to inviting and financially supporting
researchers who identify with traditionally underserved backgrounds in science. The 2023 GRC/GRS meetings
will provide participants with an ideal setting to explore how research at very different levels relate to one
another, facilitating new ideas and collaborations.

Public health relevance
Project Narrative Synthetic Biology research to understand and modify DNA, genes, proteins, cells, and biological systems has and will continue to lead to new treatments for genetic disorders, antibiotic resistance, infectious diseases, cancers, and other diseases and disorders. Synthetic Biology research has also contributed to advances in agriculture, nutrition, and food availability. The GRC and GRS on Synthetic Biology bring together researchers from across the field and with different expertise, allowing them to share information and create new solutions to challenging problems in human health and well-being.